CT and CXR Phenotyping Platform for Assessing COVID-19 Susceptibility and Severity

Abstract
COVID-19 was declared a pandemic by WHO on March 11. Since then, there have been 8.15 million
confirmed cases worldwide with a case fatality rate ranging from 16.3% to 0.1%. In the US, there have been
2,187,202 cases with a 5.4% case fatality rate as of June 16, 2020. The magnitude of this infectious disease
has stressed the need to develop novel methodologies to define who are at the highest risk of developing
acute symptoms. X-Ray (CXR) and Computed Tomography (CT) play a fundamental role in the detection and
follow-up of the COVID-19 lung injury. It also provides a unique opportunity to define quantitative biomarkers
that may identify susceptible subjects to the acute phase of the disease using pre-infection and early infection
radiological exams.
This proposal's broad objective is to provide a better understanding of acute COVID-19 susceptibility markers
based on artificial intelligence approaches on radiological exams, both CT and CXR. CT offers a unique way to
phenotype the lung and its changes. Subtle changes of normal parenchyma have been associated with
systemic inflammation that can be detected on CT. We hypothesize that susceptible subjects for acute COVID-
19 disease evolution will express inflamed normal parenchymal signatures that can be measured on CT scan
prior to the infection or in the early phases of the viral infection. We will develop new computational
approaches to identify radiographic patterns consistent with inflamed normal parenchyma as well as early
COVID-19 injury and compute radiomics signature that can capture the heterogeneity of the radiographic
expression for each lung pattern. We will define new CT-based biomarkers for acute COVID-19 susceptibility
using Gradient Boosting decision trees and feature importance. We will then translate the quantification of the
most relevant features in CXR image using image translation approaches based on deep neural networks.
Finally, we will integrate these automated tools in the CIP workstation using clinically friendly end-to-end
workflows to empower clinical investigations across the world. We will continue the support and dissemination
of this tool across the research community. Over the last 15 years, our group has developed the Chest Imaging
Platform (CIP), an NIH-funded open-source software tool for the automated phenotyping of chest CT scans
that is widely used in the chronic lung disease research community. Since the beginning of the pandemic, CIP
has been used to the characterization of COVID-19 using existing densitometric metrics. Our commitment to
open science in the form of open toolkits that are freely distributed is fundamental to catalyze the application of
AI and imaging in the context of this pandemic.

Public health relevance
Project Narrative As of June 16, there has been 2.18 million confirmed cases of COVID-19 in the United States with 118,435 fatalities. Unlike many other diseases, only general epidemiological factors are available for describing the susceptibility to COVID-19 and its acute phase. Biomarkers computed from CT and CXR images of the chest provides a personalized approach to define prognostic markers of disease susceptibility.